Research Education Component

Research Education Component Summary
The goal of the Research Education Component (REC) is to create a cadre of collaborative scientific leaders in
research on AD/ADRD. Our REC structure uses a comprehensive, multi-disciplinary, diverse and inclusive
approach. We designed our integrated program to assure trainees will acquire a keen appreciation of the
heterogeneity within AD and between it and other neurodegenerative diseases, as well as a comfort with
thinking about how basic findings inform clinical research, and clinical findings inform basic research. With the
REC, the Penn ADRC will implement NAPA milestones to improve and increase cross-disciplinary training,
including for individuals who are members of under-represented populations, and of different career levels of
scholars. The REC is well-integrated with the Clinical, ORE and Admin Cores in order to promote and execute
training opportunities, and with all ADRC Cores to create scholar-specific mentoring and training plans and
develop data and didactics presentations. We will provide training to 4 categories of trainees: (1) fellows who
have completed their residency (MD & MD/PhD), (2) doctoral/postdoctoral trainees, (3) junior faculty (defined
as instructor or early [<3 years] assistant professor, PhD, MD or MD/PhD), and (4) undergraduate and
graduate students from underrepresented minority groups who participate in mentored research experiences
over a summer semester or during a research block. The specific aims of the REC are the following: 1.
Assemble and provide ongoing training to a cadre of Penn faculty who will serve as mentors and instructors to
the REC trainees; 2. Implement a structured methodology to identity trainees spanning fellow/doctoral to junior
faculty levels, and a targeted effort to identify undergraduate and graduate students from underrepresented
minority groups; 3. Provide training that includes research design and conduct, the ethical and socially
responsible conduct of research, the value of multi-disciplinary collaborative approaches to research on AD
and related disorders, career planning (including work-life balance, leadership and goal setting), and core
research skills of writing and dissemination; and 4. Use evaluations of the faculty and trainees to revise and
update the Research Education training program, with attention to cultivating the next generation of AD
researchers, diversity and the immediate- and long-term advancement of trainees’ careers.